Pathway-guided treatment of immune checkpoint inhibitor therapy-induced colon toxicity

Abstract
Development of immune-related adverse effects (irAEs) is one of the significant challenges of current approved
cancer therapy with immune checkpoint inhibitors (ICIs) of targeting anti-CTLA4 and/or anti-PD1/PDL1. Immune-
mediated enterocolitis or inflammatory bowel disease is one of the most frequent and problematic irAE
associated with ICI therapy (simplistically termed “ICI-colitis” in the grant). The development of severe ICI-
associated enterocolitis is the most frequent cause of ICI therapy cessation and significant morbidity, which
inevitably impedes the clinical benefits of ICI therapy. The underlying mechanism of ICI-colitis remains poorly
understood. Due to the lack of mechanistic understanding, current treatment of ICI-colitis was empirically
adopted from the approaches for the idiopathic inflammatory bowel diseases (IBD), using corticosteroids as the
1st line treatment and targeted anti-TNFα or anti-α4β7 integrin as the 2nd line treatment for corticosteroid failures.
For patients with severe ICI-colitis, this approach frequently resulted in a significant delay in resuming ICI therapy
or forced permanent cessation of ICI therapy, owing to the complications of corticosteroid use itself. Clearly, it is
imperative to understand the molecular and cellular pathways of ICI-colitis to guide a more scientific and effective
management and to achieve better clinical outcomes. In our preliminary studies with colon biopsies from a small
cohort (n=18) of ICI-colitis patients, we discovered that ICI-colitis presented two subtypes by molecular pathology
and the associated responsiveness to corticosteroid treatment. One subtype has the signature of CD8 T cell
cytotoxicity in the colon and responsiveness to corticosteroids, whereas the other subtype has the molecular
signature of the idiopathic IBD and is refractory to corticosteroids but responsive to the 2nd line treatment. The
former type was associated with elevated tumor-secreted circulating soluble NKG2D ligand sMIC in the colon
and elevated serum IL-18. Notably, we have established unique animal models to recapitulate the sMIC-
associated ICI-colitis subtype. With our novel clinical findings and unique animal models, the objectives of this
proposed study are: 1) to establish clinically achievable biochemical parameters that can be used to guide a
more effective treatment of ICI-colitis through leveraging a larger cohort of archived clinically-annotated ICI-colitis
patient samples; 2) to understand the cellular and molecular mechanisms underlying the subset of ICI-colitis
associated with elevated circulating sMIC and IL-18; and 3) to explore more beneficial treatments for sMIC-
associated ICI-colitis preclinically. Through the perpetual dialogue between human samples and mouse models,
we anticipate that our study will provide the rationales for multi-institutional large cohort clinical trials to validate
the parameters for guiding a more effective ICI-colitis management and for a more beneficial therapy to treat ICI-
colitis in a subset of patients.

Public health relevance
Project Narrative Immune checkpoint inhibitor (ICI) therapy induced colon toxicity is a significant clinical problem for cancer patients. Current management of ICI-induced colitis (ICI-colitis) is empirically adopted from the management of autoimmune colitis/inflammatory bowel diseases, which has significantly interfered with the course of ICI-therapy. This proposed study aims to define new management strategies of ICI-colitis based on scientific rationales through a perpetual dialog between information derived from clinical sample and novel pre-clinical ICI-colitis animal models. We hope the outcome will help to improve the benefit of ICI therapy.